Single cell determinants of brain in the context of viral persistence in SIV/cART/cocaine non-human primates

PROJECT SUMMARY
Drug abuse and HIV infection co-exist and are difficult to study due to challenges in people living with HIV
(PLWH) who abuse drugs. One of the prime areas of pathogenic interactions of HIV and drugs of abuse is the
brain, which carries additional study limitations. To obtain rigorous data on the effects of HIV and cocaine on
the brain, we will utilize well-studied nonhuman primate animal model, Simian immunodeficiency virus (SIV)-
infected and uninfected control rhesus monkeys, in the presence or absence of cocaine. Single cell
sequencing assays enable cell type-specific analysis of the role of specific cell types in both healthy brain
function and disease. The overall objective of this proposal by multidisciplinary team of investigators is to
reveal the single cell determinants of brain in the context of viral persistence in SIV/cART/cocaine non-human
primates. Simultaneous single-cell RNA sequencing and single-cell Assay for Transposase- Accessible
Chromatin sequencing (scMultiome-seq) will be carried out on cells isolated from the prefrontal cortex (PFC),
striatum, and hippocampus from each animal. Data will be processed and analyzed to derive cell type-specific
regulatory programs and changes in these programs that regulate neuropathogenesis in the primate brains.
These studies will provide unique and valuable insights into SIV/cocaine/cART interactions in the brain while
also providing crucial experimental validation of the findings in humans. Successful completion of these
innovative single-cell studies and data analyses methods will generate a single cell transcriptome and
epigenome atlas of cellular part list for three NIDA-relevant brain regions, PFC, striatum, and hippocampus.
These results will illuminate novel insights into transcriptomic and epigenetic landscapes of CNS and how
they are altered by HIV and cocaine use.

Public health relevance
PROJECT NARRATIVE People living with HIV (PLWH) are at the higher risk for impaired cognitive functions due to higher use of cocaine that could affect their immune functions and exacerbate CNS (central nervous system) impairment. However, little is known about the HIV harboring cell types in brain, effect of therapy on specific CNS cell types, and the modification of brain functions by cocaine use. Results of proposed innovative single-cell studies employing simian immunodeficiency virus (SIV) infection and nonhuman primate animal models will generate cellular part list for brain regions and will illuminate novel insights into transcriptomic and epigenetic landscapes of CNS and how they are altered by viral infections and cocaine use.